Deciphering neural origins of interhemispheric striatal resting-state functional connectivity using simultaneous chemogenetic fMRI and triple-spectral fiber photometry

PROJECT SUMMARY
The brain is a complex patchwork of interconnected regions, and network approaches have become
increasingly useful for understanding its functional architecture. Resting-state fMRI (rs-fMRI) has emerged as
the prominent tool for non-invasive investigation of large-scale functional networks at rest. However, little is
known about the neuronal mechanisms responsible for the formation of rs-fMRI functional connectivity. This
knowledge is critical to interpret rs-fMRI data, causally model brain states, predict behavior, and design network-
based treatment regimens for neuropsychiatric and neurological disorders. Among all brain regions, striatum
may represent a unique example to study the neural origins of rs-fMRI. Findings in literature have repeatedly
shown that rs-fMRI signals in the striatum of both hemispheres are highly synchronized, yet viral tracing studies
showed no direct anatomical connections between bilateral striatum. This raises an intriguing question – how is
bilateral striatal rs-fMRI connectivity formed without any direct anatomical connection? Addressing this question
could have major implications in understanding what rs-fMRI signals in striatum represent. Three possible
scenarios may explain the existence of interhemispheric striatal rs-fMRI connectivity: (1) synchronous firing of
striatal GABAergic MSNs, (2) synchronous release of glutamate from cortico-striatal or thalamo-striatal
projections, and (3) synchronous release of dopamine from nigro-striatal projections. Here, we hypothesize that
(2) and (3) are the origins, with (3) being the most prominent source. We formed such a hypothesis because (1)
rigorous prior study from our team members suggested that MSN firing between two hemispheres is
asynchronous, and (2) dopamine neurons are well known pacemaker cells. Our team recently pioneered a multi-
channel, spectrally resolved, MR-compatible fiber photometry technique that is ideal to decipher the neural
origins of rs-fMRI. Rigorous prior research has demonstrated our unique ability to simultaneously measure
multiple fluorescent sensor activities across multiple brain regions during fMRI. In Aim 1, we will measure three
major neuronal components with simultaneous fiber-photometry and fMRI in bilateral striatum. Those
components are: (1) presynaptic glutamatergic releases; (2) presynaptic dopaminergic releases; and (3)
postsynaptic calcium-weighted neuronal activities. We hypothesized that interhemispheric striatal fMRI
connectivity might be related to presynaptic dopamine releases in the striatum. In Aim 2, we will interrogate the
causal influence of glutaminergic and dopaminergic projections on interhemispheric striatal rs-fMRI connectivity
using chemogenetics. We hypothesized that silencing unilateral dopamine activity in the SNc may interrupt
interhemispheric striatal rs-fMRI connectivity. We will unilaterally express inhibitory DREADD in striatum-
projecting cortical neurons, in MSNs, and in nigral dopamine neurons, and repeat the same experiments as in
Aim 1 before and after the administration of DREADD agonist deschloroclozapine (DCZ). In summary, this
project aims to address significant missing knowledge about the neural correlates of interhemispheric striatal
fMRI connectivity. The investigators have a strong track record in this line of research and will bring Innovation
to the field by bridging local cellular imaging and analytical methods to address novel hypotheses well supported
by rigorous prior research.

Public health relevance
PROJECT NARRATIVE We propose to elucidate the neural origins of interhemispheric striatal resting-state fMRI (rs-fMRI) connectivity using simultaneous fMRI and spectrally resolved triple-color fiber photometry. It is of paramount interest to understand the mechanism by which noninvasive rs-fMRI signals is formed. Successful completion of this work will provide evidence-based interpretation of the rs-fMRI connectivity results between striatum of the two brain hemispheres, which is crucial for motor control, cognition, motivation behavior, and several neurological disorders such as Parkinson’s disease, Huntington’s disease, stroke, and neurodegeneration.